Hedgehog signaling regulation of postnatal tongue and taste organ morphogenesis

Abstract
The tongue has a major developmental trajectory during suckling and weaning periods as they adapt for
changes in feeding patterns and movement for speech. This growth encompasses numerous and extreme
changes, including increases in anterior tongue taste organ fungiform papilla (FP) taste cell number and size,
conical keratinization of non-taste filiform papillae (FILIFP), thickening of stroma and biochemical changes in
muscles. However, knowledge gaps remain regarding the molecular mechanisms orchestrating this growth in
different anatomical compartments of the postnatal tongue. Hedgehog (HH) signaling is vital for embryonic
tongue development and taste organ maintenance in adults, but its role in postnatal tongue is not clearly
elucidated. We have strikingly discovered that it extends beyond FP in the early postnatal tongue, specifically
within FILIFP, suggesting a potential role for HH signaling in FILIFP maturation. To challenge the current
paradigm, we will identify HH pathway components and HH-regulated target genes in early postnatal FILIFP
epithelium using RNA and DNA sequencing tools (Aim 1a). We will then describe how HH signaling and its
candidate FILIFP-specific target genes contribute to postnatal FILIFP maturation and function by using an
epithelium-specific genetic mouse model to inhibit the pathway (Aim 1b). Further, HH receptors CDON, GAS1
and PTCH1, despite their known relevance in other postnatal tissues, remain uninvestigated in the postnatal
tongue. We observe that their expression is largely non-overlapping in FP and FILIFP epithelium, stroma or
lingual muscles during the first postnatal week. Importantly, their expression patterns shift in coordination with
tongue and taste organ maturation by postnatal day 21. We hypothesize that the distinct spatiotemporal
expression of HH receptors in the early postnatal tongue differentially regulates morphogenesis in different
anatomical compartments and restricts their function in late postnatal stages to maintaining taste organs.
Therefore, our second aim will employ epithelium-, stroma- or muscle-specific conditional loss-of-function
approaches for Cdon, Gas1 or Ptch1 to elucidate their functions in feeding and taste. We will describe the
individual contributions of Cdon, Gas1 or Ptch1 to the growth of FP and FILIFP (Aim 2a), stroma (Aim 2b) and
muscle (Aim 2c) across early and late postnatal stages. Our goals are to unveil the role of HH signaling and its
essential cell surface receptors in the postnatal development of the lingual epithelium, stroma and muscles,
and to elucidate the functional consequences of HH pathway/receptor inhibition on the juvenile feeding and
taste system. These findings will provide a molecular understanding of tongue maturation after birth across
different anatomical compartments, laying the groundwork for improved diagnostic and treatment strategies for
pediatric tongue-related abnormalities.

Public health relevance
Narrative Despite the vital role of Hedgehog (HH) signaling in several postnatal organs, there is limited knowledge about its regulation in the tongue at postnatal stages, when taste and non-taste organs, stroma and muscles are developing and completing their morphogenesis. Pediatric neoplastic or acquired tongue lesions can disrupt feeding and speech, leading to poor nutritional status and low quality of life. The research proposed here utilizes genetic mouse models to investigate the role of HH signaling in postnatal tongue maturation to advance the knowledge of regulatory controls of tongue maturation that can be used to lay a foundation to evaluate the role of HH signaling in pediatric tongue lesions.